Roswell Park CCSG-Admin Supp-Community Outreach Capacity- National Outreach Network - additional funding

Abstract. The Haudenosaunee are one of the few Native American (NA) tribes occupying original lands in the U.S. who have not been displaced. This confederation of six tribes has an active presence in New York State (NYS), including the catchment area of Roswell Park Comprehensive Cancer Center (RP). Cancer is one of the top ten leading causes of death in the RP Native American and rural NY catchment areas. Colorectal cancer (CRC) is the sixth leading cause of death among these populations. NA and rural communities are requesting increased cancer education, navigation, outreach and will additionally benefit from greater inclusion in research and treatments such as Clinical Trial (CT) participation. To address this gap, the aims of this project are the continuance of integrated virtual, community and clinically based cancer outreach, education model for both CRC and CTs to increase knowledge, intent and behaviors among NA and rural community members. This will be accomplished by collaborative efforts from the cancer center and tribal and rural media networks promoting ongoing outreach and engagement. The community health educator (CHE), a member of both the Community Outreach and Engagement (CoE) and the Center for Indigenous Cancer Research (CICR), will continue ROOTS (Resources, Optimizing Outreach, Teaching and Science) programming for Native American and NY Cancer Prevention. Programming will be delivered via virtual implementation and online assessment under the guidance and support of the CICR community advisory board. Evaluation and impact will be measured by the primary outcome of pretest-posttest survey of knowledge and behavior change. Secondary outcomes include triangulated aggregated tribal and rural data analyses to look at change for the northeast Indian Health Service area. Our long-term sustainability goal is the continuance of community outreach within our CCSG for NA and rural communities and the sustainable integration into both RP and tribal services delivery systems for ongoing dissemination of in-person and virtual, culturally tailored, evidence-based cancer education, screening and treatment services, and access to clinical research. Overall, results are expected to increase community-based collaboration and decrease cancer disparities across the region through an increase of knowledge about CTs and an increase in knowledge of CRC screening. .

Public health relevance
ROOTS or Resources, Optimizing Outreach, Teaching and Science for Native American and rural populations focuses on the continuance of virtually adapted clinical trial and colorectal screening education to decrease cancer health disparities while increasing knowledge about culturally tailored research and screening processes.